Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The mission of the Center for Gastrointestinal Biology and Disease is to promote multidisciplinary research to
lower the burden of digestive diseases. The Administrative Core provides organizational, operational, and
financial strategies for the DDRCC to achieve its mission. The Administrative Core ensures the coordination
and integration of Center components and activities, including core laboratories, enrichment, and the
pilot/feasibility program. The Administrative Core is responsible for administering the DDRCC grant assuring
that the Center complies with federal regulations, submits reports in a timely fashion, and has a balanced
budget. The Administrative Core includes the Center co-directors: Robert Sandler, MD, MPH and R. Balfour
Sartor, MD. There are two Associate Directors, Scott Magness, PhD (basic research) and Evan Dellon, MD,
MPH, (clinical translational research), and two Assistant Directors, Casey Theriot, PhD (NC State University)
and John Rawls, PhD (Duke University). Temitope Keku, PhD, is the CGIBD Director of GI Research
Enrichment and Diversity Initiatives. Michael Kappelman, MD, MPH serves as Director of Community
Engagement. The co-directors and administrator comprise an Operations Committee that meets weekly. An
Executive Committee composed of directors, core directors and at large members establishes goals, meets
quarterly to set standards of use of cores, reviews P/F studies, selects members, plans the enrichment
program, and interacts with the Internal and External Advisory Boards. An External Advisory Board provides
advice and oversight and makes final section of Pilot/Feasibility awards. An Internal Advisory Board (IAB)
provides additional oversight and helps advocate for the Center. The IAB includes a community representative.
The specific aims of the Administrative Core are: 1) To provide the leadership necessary to promote
cooperative, successful scientific interactions among a multidisciplinary group of center participants. 2) To
establish and maintain appropriate committees, such as the broadly based Executive Committee, Internal
Advisory Board and External Advisory Board. The committees provide ongoing scientific direction and rigorous
constructive review of core laboratories, pilot/feasibility studies and the center. 3) To evaluate and update the
membership. 4) To arrange fiscal, administrative, and strategic oversight necessary for efficient, cost-
effective accomplishment of Center goals. 5) To establish and maintain lines of communication with
institutional leadership and members to inform the scientific community and the public about the Center and
to inform membership about events. 6) To foster training and career development of young investigators. 7)
To promote interaction with other DDRCC's, the NIDDK and other individuals, groups and organizations
dedicated to easing the burden of digestive diseases. The Center benefits from considerable institutional
support to enable it to accomplish its mission.